Technical Support for Surveillance, Epidemiology, and End Results (SEER)-Medicare Health Outcomes Survey (MHOS) Data Set

The contractor will support linked SEER-MHOS data file, which
includes but is not limited to: updating linkage at regularly scheduled intervals, providing summary statistics, evaluating the quality of the merged file, maintaining programs and documentation on linkage process in situations where replication might be required.